Tissue Engineering Resource Center: Admin-Core

SUMMARY
The Administrative Core of the Center will provide the exchange of information, strategic planning
and coordination of the Center, guide the selection and progress of collaborative projects (CPs)
and service projects (SPs), monitor accomplishment of the aims for each component of the
Center. The Core will also oversee the budget allocations and the development and utilization of
resources, and oversee the dissemination and outreach. Overall, the Administrative Core will
serve as a hub for coordination of the Center and all its components. The Administrative Board
(PD/PI, leads and co-leads of all TR&Ds) will oversee the overall operation of the Center. They
will be assisted by three staff members (Technical Coordinator, Research Engineer, Grants
Manager) and three postdocs representing the trainees. Three specific aims will be pursued. Aim
1: Management of the Center’s activities. The Administrative Core will provide the financial
support, logistics and oversight of each individual TRD, CP and SP, and foster synergistic
interactions between the Center’s components towards accomplishing the Center’s mission. Aim
2: Management of Training, Dissemination and Outreach. The Administrative Core will plan and
oversee the interactions within the Center and with external collaborators and users,
dissemination of the Center’s results and capabilities to the academic, clinical and commercial
sectors, and outreach to the community. Aim 3: Management of Technology Translation and
Commercialization. The Administrative Core will oversee the CPs and SPs, and the translation
and commercialization of the Center’s products and technologies.